WHITE MATTER MRI HYPERINTENSITIES GD-DTPA PERFUSION MRI PROTON MAGNETIC RES SPEC

Identification of the ischemic nature of asymptomatic MRI T2 hyperintensities, by demonstrating decreased CBV and increased lactate within them compared to normal brain.